IGF::OT::IGF INFRASTRUCTURE HARMONIZATION FOR DCP DESK SUPPORT

Develop a consortia website to be known as CONSORTIASYS to support and facilitate the creation of the DCP Central Institutional Review Board (CIRB).